Developmental Research Program

The Developmental Research Program is charged with supporting the development of pilot studies with the potential to become full projects in translational Breast cancer research, as part of the Breast SPORE.